Regulation and Function of the Type 2 Diabetes-Associated C2CD4A/B Locus

PROJECT SUMMARY
Diabetes afflicts approximately 29 million adult Americans (9.3% of the total population), 90-95% of whom have
type 2 diabetes (T2D). T2D is a complex disease with both genetic and environmental components and
ultimately manifests when pancreatic islets fail to secrete sufficient insulin to compensate for increased insulin
resistance. Despite the success of genome-wide association studies (GWAS) in linking >100 loci to islet
dysfunction and T2D, we still lack the mechanistic insights necessary to develop novel treatments and
preventions. Detailed molecular and phenotypic analyses of each T2D-associated GWAS locus are thus
essential to determine how they contribute to islet dysfunction and diabetes. We have recently linked altered
C2CD4A/B expression to genetic risk of islet dysfunction and T2D. Our overall objective is to understand the
islet/beta cell regulation and function of the C2CD4A/B locus in physiologic and diabetogenic states. We
hypothesize that these genes regulate stimulus-secretion coupling and that chronic activation of C2CD4A/B by
genetic and/or environmental risk factors contributes to the declines in first-phase insulin secretion that are
hallmarks of the early stages of T2D. To test this hypothesis, we will determine the regulatory circuitry
controlling C2CD4A/B responses to inflammatory stressors and determine the effect of T2D-associated GWAS
variants on C2CD4A/B activity (Aim 1). In parallel, we will dissect the beta cell functions of C2CD4A and
C2CD4B in glucose-stimulated insulin secretion (Aim 2). Finally, we will assess the in vivo effects of deleting
these genes in a polygenic T2D mouse model (Aim 3). Together, these aims will provide fundamental,
mechanistic insights into the regulation and function of the C2CD4A/B locus and will delineate the roles of
these genes in islet function and T2D pathogenesis. More broadly, we anticipate the study of this locus will
provide new perspectives/insights into the mechanics of insulin secretion and beta cell compensation. The
cellular and mouse models that we will create to dissect the regulation and function of the C2CD4A/B locus in
diabetes pathogenesis will empower future analyses of novel therapeutic molecules and approaches to target
this locus to prevent and treat diabetes.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Type 2 diabetes (T2D) is a complex disorder influenced by both genetics and lifestyle that places substantial burden on the medical and public health systems. Dysfunction and failure of the pancreatic islets are central to type 2 diabetes. In this project, we will investigate how the C2CD4A/B locus, which we have recently linked to islet dysfunction and T2D susceptibility, is involved in regulating the pancreatic islets—knowledge that will open up new avenues for diabetes treatments.